Administrative and Mentoring Core

PROJECT SUMMARY/ABSTRACT – Overall Component
In Phases I & II of the Institute for Biogenesis Research (IBR) COBRE, the Administrative and
Mentoring Core was able to develop unique and effective administrative strategies in order to coordinate the
day-to-day management of the center grant, which accommodates faculty and staff on two separate
campuses. The Administrative and Mentoring Core successfully designed and enacted a mentoring strategy
that evolved with the intensive participation of the External Advisory Committee (EAC), which remains highly
dedicated to the development of the IBR as demonstrated by their continued participation in Phase III. In
Phase II, we initiated a partnership with the Department of Obstetrics, Gynecology & Womens Health (Dept.
Ob/Gyn) that we feel is essential to our continued growth and expansion as a Biomedical Center of Research
Excellence in the field of developmental and reproductive biology. Our IDeA trained and mentored basic
science researchers have matured to the point that we can pursue the goal of developing a translational arm to
our research. In this Phase III application, we have applied our experience to the design of our current
strategies for administering the IBR COBRE and to use the resources it provides to maximally enhance the
development of the institution and the IBR's research capacity. The overall goal of this core is the same as
that of the application as a whole, which is to strengthen and transform the IBR into a multi-disciplinary, fully
translational reproductive biology research center that will become independent enough to be sustained on
extramural grant support for its future development. The particular emphasis of the Administrative and
Mentoring Core is the coordination of all the resources to co-ordinate the productivity of the two cores, and the
Translational Pilot Project Program to complete the development of the IBR to sustainability. This will be
accomplished through three Specific Aims. Specific Aim 1: Enhance the Administrative and Mentoring Core to
effectively coordinate and manage the sustainability of the two technical cores. The major goal of the
Administrative Core will be to coordinate the resources supported by the IBR COBRE, including the EAC,
external scientific mentors, visiting scientists, the Transgenic Mouse, ICSI and IVF Core, the Molecular and
Cellular Immunology Core, and shared instrumentation for the benefit the entire Center. Specific Aim 2:
Develop and implement a Translational Pilot Project Program. We will leverage a strong partnership the IBR
has developed with the Dept. Ob/Gyn to develop a translational research arm for the IBR COBRE through an
innovative use of the pilot program project. Specific Aim 3: Develop and implement an external mentorship
program.